Data Management and Statistical Core (DMS)

Abstract: Data Core
The Data Management and Statistical Core will provide informatics and statistics support
for ADRC related dementia related research. The multimodal nature of data collected to
investigate the etiology, pathogenesis, diagnosis, treatment, and prevention of AD requires robust
informatics, data management and statistical approaches. Specifically, we will provide for:
standardized collection of local assessments, scales and enrollment status, de-identifying, storing
and tracking neuroimaging data, web-based systems for the databasing, protection, tracking and
access of all data to qualified and authenticated scientists. We will ensure timely and accurate
data entry to NACC related UDS and neuropathology databases and provide biostatistical
consulting to ADRC investigators in the design, coordination and analysis of ADRC-related
projects, including development projects.
We will establish connections and coordinate with both local and national efforts to share
and exchange well curated and comprehensively described data. Finally, we will provide
education and training in design, statistical models and informatics in coordination with the ORE
core. Existing strengths of our Core include data management and biostatistical resources
embedded within the USC Mark and Mary Stevens Neuroimaging and Informatics Institute (INI)
and the Department of Preventative Medicine. We have strong leadership by investigators
involved in many of the national and global AD research related efforts and possess the resources
necessary to insure success in our core.